Anti-inflammatory Cell Based Repair of Intervertebral Disc Degeneration

This application is for a diversity supplement for a graduate (pre-doctoral) student that will be
advised by the PI Dr. Nadeen Chahine’s on a research project related to this NIH parent award.
The candidate will be a new PhD graduate student at Columbia University Department of
Biomedical Engineering (PhD program). The candidate is a female engineer (U.S. citizen) from
an underrepresented race/ethnic group in STEM, as defined by the guidelines provided by NSF
and NIH on workforce diversity. The candidate’s graduate training in Biomedical Engineering (PhD
program) at Columbia University enhances the diversity of the biomedical research workforce.
The diversity supplement project will examine the effects of substrate stiffness and intervertebral
disc (IVD) derived matrices on promoting anti-inflammatory cell based repair of the degenerated
IVDs. The diversity supplement project is a direct extension of the scope of the parent R01 studies
on anti-inflammatory cell based repair of IVD degeneration. A greater understanding of how
physical and mechanical cues regulate cell based repair of the IVD is expected to provide
therapeutic advances for treatment of disc degeneration and back pain.

Public health relevance
Discogenic back pain, is a leading cause of disability, and involves degenerative changes of the intervertebral disc. Only a small subset of patients responds favorably to existing treatments, and there is a need for alternative options, including regenerative therapies. We are developing and optimizing use of anti-inflammatory cells for disc repair in hope that it improves outcomes or patients with back pain and degeneration.